Decoding the Molecular and Antigenic Interactions in Orthopox Virus Entry

The initial interaction between a virus and a human cell represents the critical first step in viral infection, making
its prevention a primary focus in antiviral therapy. The viral entry process remains largely unexploredfor orthopox
viruses, which caused an escalating number of outbreaks in recent years. In 2022, the mpox virus (MPXV) clade
2b instigated a multi-country outbreak involving both endemic and non-endemic countries, leading to an
international health crisis (WHO) and a public health emergency declaration (U.S.). In 2023, the Democratic
Republic of Congo (DRC) experienced an outbreak of the more lethal MPXV clade 1 ( with a fatality rate of up to
10%) linked to sexual transmission. Individual proteins involved in the multi-protein entry/fusion process and
targets for neutralizing antibodies were described, yet a comprehensive understanding of orthopox virus entry is
missing. This leaves a blind spot in understanding the sequential procedure of viral entry, the intricate interactions
among the numerous proteins involved, and the implications for vaccine design and therapies. Here we propose
to elucidate the molecular process of orthopox virus entry through side-by-side comparison of MPXV and
vaccinia virus (VACV) using an integrative approach that combines methods from virology, proteomics, and
immunology. Aim 1: Identifyand characterize the interactions of virus andcellproteins during attachment
and entry, and determine antibody accessibility to viral entry proteins. We will conduct in vitro orthopox
virus infections of Vero E6 cells to understand interaction processes during viral entry. We will analyze multiple
time points within the initial 30 minutes post-infection to track sequential interactions between viral and cellular
proteins during the attachment and entry phases. Coupling trifunctional crosslinking of cellular and viral proteins
with mass spectrometry will reveal virus–host interactions. We will use RNA interference to confirm the relevance
of the identified cellular receptors for orthopox virus entry and infection. We will classify cellular proteins by
enrichment analyses and pathway networks. Furthermore, we will use: 1) crosslinking to polyclonal antibodies
(purified fromsera of mpox convalescent patients and vaccinees), and 2) quantitative analysis of the biotinylated
viral surface proteins to identify antibody-accessible entry proteins on MPXV and VACV virions. Aim 2: Map
antigenic properties of the viral proteins from the orthopox virus entry cascade. We will use serum
antibodies from mpox convalescent and/or vaccinated individuals, collected during the 2022 NYC mpox
outbreak, to study recently reported and newly identified viral proteins of the entry cascade. Together, these
approaches will address fundamental questions in orthopox virology and decipher the viral entry process and
antibody exposure during entry at the molecular level. The insights gained will provide unprecedented detail to
help understand how orthopox viruses infiltrate cells, providing critical knowledge to design next-generation
vaccines and treatments.

Public health relevance
This project aims to elucidate the largely unexplored process of orthopox virus entry into human cells, a critical step in viral infection. Using an integrative approach combining virology, proteomics, and immunology, we will study the sequential interactions of virus and cell proteins during attachment and entry, identify antibody exposure of viral proteins during entry, and map the antigenic properties of entry proteins. The insights gained will enhance our understanding of how orthopox viruses infiltrate cells and inform the design of next-generation vaccines and treatments to prevent infections.